Brain structure and function in infants

Project Summary/Abstract
For almost 100 years, a large number of electrophysiology studies have reported on resting-state (RS)
neural activity in humans. This research often focuses on RS alpha-band activity (8-12 Hz in adults), as
RS alpha activity it is commonly interpreted as reflecting the brain's readiness to process information,
predicting task performance and processing speed, and being integral to coordinating local- and long-
range functional connectivity. Infant RS studies seek to understand infant RS neural processes and the
maturation of these processes, with the first two years of life a peak period of neural reorganization, and
with variation in the maturation of RS activity contributing to normal variation in development as well as
clinical disorders. In infants and toddlers, this line of research is constrained by difficulty obtaining
prototypical high SNR eyes-closed RS electrophysiology measures, with almost all infant studies
obtaining RS measures while infants view visual stimuli, and with an eyes-open condition not generating
a robust infant `alpha' response. During the current cycle of this R01 (locally referred to as Babies' Brains
Change (BBC)), we developed methods that overcome barriers that have to date limited progress. Our
intention is that findings from this continuation R01 will provide direct tests of theories of infant
maturation of brain function, structure, and chemistry and their relationship to each other and
behavior, change the way infant RS electrophysiology studies are conducted, and show the way
forward for further discoveries about those relationships. Progress will be made via (1) the use of an
eyes-open dark-room (DR) task advanced by the PI and which provides RS measures with a high-SNR
dominant oscillation response in awake infants, (2) using recently developed algorithms to parameterize
the RS power spectrum to obtain estimates of RS periodic activity (e.g., the canonical RS dominant
oscillation) and RS aperiodic activity (i.e., the `background' neural activity), (3) assessing RS activity in
brain space so that regional differences in RS neural activity can be identified, and so that hypothesized
associations between RS neural activity and brain structure (gray and white matter), brain chemistry
(glutamate (Glu) and gamma-aminobutyric acid (GABA)), and behavior can be optimally evaluated, and
(4) obtaining temporally dense brain measures as understanding brain development requires assessing
maturational processes. At Time 1, evaluable data (MEG measures of infant RS activity, MRI measures
of gray and white matter, MRS measures of Glu and GABA, and developmental milestone measures) will
be obtained from 70 infants, with a 4-month interval between visits, and with a total of 4 visits. It is
predicted that the project findings will identify regional differences in the maturation of RS neural activity,
show that brain structure and chemistry predict the structure of the RS activity, and that RS measures will
predict the time to developmental milestones (e.g., age when first walking).

Public health relevance
Project Narrative Resting-state (RS) neural activity shows rapid changes across the first years of life (the background against which brain function and behavior emerge), with RS activity in older children and adults indexing the inhibition of task-irrelevant processes, associated with top-down cognitive control processes, central to how local networks process information, and associated with our ability to quickly process information. Our understanding of RS activity in infants and toddlers is limited by challenges that have so far hindered research in this area, with this project making progress via (1) the use of a RS task optimized for infants and toddlers, (2) using recently developed algorithms to more accurately measure RS activity, (3) obtaining measures of RS activity in brain space to test theories associating RS neural activity with brain structure, chemistry, and developmental milestones, and (4) obtaining temporally dense brain measures as understanding brain development requires assessing maturational processes. In this prospective cohort design, brain development and behavior will be examined at baseline in infants 0 to 4 months (N=70) and then longitudinally at 4-month intervals with the final visit at 12 to 16 months (4 visits in total), with finding greatly extending our understanding of infant/toddler resting-state neural activity.